Biorepository and Tissue Technology Shared Resource

BIOREPOSITORY AND TISSUE TECHNOLOGY SHARED RESOURCE ABSTRACT
The Biorepository and Tissue Technology Shared Resource (BTTSR) is a critical component of the
infrastructure supporting translational studies. It is founded on a well-established institutional model integrating
tissue procurement, processing, storage, and multimodal (histologic, immunohistochemical, and molecular)
analyses with traditional epidemiologic, clinicopathologic and outcome parameters through a highly evolved
bioinformatics system. Alfredo Molinolo, a physician pathologist with more than 40 years’ experience in human
and experimental pathology, is the Director of the BTTSR. As of January 2018, the Biorepository (BRPT) is
now a full College of American Pathologist (CAP)-accredited resource. Under its own IRB approved protocol
(IRB# 090401), the BRPT integrates patient consenting, prospective procurement services, protocol and
standard operating procedure design, tissue processing, and storage. Jason Sicklick, a GI surgeon, is the
Deputy Director of the BRPT for clinical affairs. Sharmeela Kaushal is the BRPT Manager overseeing
operational aspects of the BRPT under NCI and CAP guidelines. Three coordinators for patient consenting and
two technicians for tissue processing assist her. Valeria Estrada, the Assistant Director for Tissue Technology,
supervises the Tissue Technology Shared Resource (TTSR). She is a well-trained academic pathologist with
experience in management and employment policies, and extensive knowledge of standard/novel pathology
techniques. She supervises four dedicated histotechnicians. TTSR services include tissue fixation, processing
and sectioning, paraffin and frozen, routine stains, special stains, individualized immunohistochemistry (IHC)
and immunofluorescence (IF) assays, antibody optimization and validation, digital imaging and digital image
storage, mouse phenotyping, tissue microarrays developing and construction, multiplexing IHC and IF, and
pathology consultation and training, among other services. Since July 2016, the TTSR equipment inventory
has grown with the acquisition of, among other equipment, an AT2 ScanScope slide scanner, a Gemini H&E
stainer, and a Biocare Medical immunohistochemistry autostainer. Over the past 5 years, the BTTSR has
supported 174 users, including 89 MCC members and 11 members from the Salk and Sanford-Burnham
Prebys NCI-designated Cancer Centers.